Analysis Core

ABSTRACT: ANALYSIS CORE
The Analysis Core (AnC) plays a critical role in the activities and productivity of the Michigan Center for
Contextual Factors in Alzheimer’s Disease (MCCFAD). Supporting MCCFAD’s three priority areas of:
epidemiology, health economics, and culturally sensitive care as well as the long-term goal to advance ADRD
relevant social and behavioral science research in underserved and underrepresented communities while
diversifying the research workforce dedicated to healthy aging, the AnC ensures the highest possible impact of
our Center’s research and discoveries. Building on our successes in intensively mentoring both primary and
secondary data projects, we will formally expand our educational programs beyond culturally sensitive
measurement to equity-based analysis and interpretation, promote sustainable mentoring that is both flexible
(to the needs of each AD-RCMAR Scientist [RS] and project) and proactive (in ensuring essential skills are
developed), and facilitate the use of MCCFAD’s new Research Volunteer Directory (RVD) for more inclusive
research. Corresponding to these areas of importance, the AnC proposes three Specific Aims: Aim 1: Provide
an enriched environment to ensure culturally sensitive and scientifically valid measurement, analysis and
interpretation; Aim 2: Provide flexible and proactive mentoring in state-of-the-art methods, analysis and
software; Aim 3: Disseminate methodological developments in culturally sensitive recruitment, measurement
and analysis approaches; increase access to new data resources produced. The AnC ensures thoughtful and
thorough methodological approaches and provides consultations at every stage of Center-wide analytic
activities and RS projects. They will continue to work closely with the Research and Education Core (REC) to
assist, mentor and support RS to become independent investigators in ADRD related research by providing an
enriched learning environment to increase their analytic and research skills. They will also continue to work
closely with the Community Liaison and Recruitment Core (CLRC) to ensure culturally sensitive measurement
and support data visualizations and data access involving the RVD. With our multi-disciplinary and highly
experienced AnC leadership team and Center faculty, the AnC is exceptionally well-equipped to ensure that
the MCCFAD makes seminal contributions to innovative ADRD disparities research across the region and
nationally.